Single Cell Analysis of MAPK Signaling Dynamics in Multicellularity

Project Summary
Cells have a remarkable ability to reproducibly respond to a changing environment even with promiscuous
protein-protein interactions, stochastic gene expression, and macromolecular crowding. Our goal is to identify
and characterize the mechanisms that robustly amplify signaling events over noise to govern cell biology and
ultimately coordinate collective cell behavior. We use as a model the Mitogen Activated Protein Kinase (MAPK)
pathway, a conserved signaling network involved in virtually all aspects of cell biology. Our focus on quantitatively
understanding the timing of signaling events at the single cell and single molecule levels in the context of
physiologically relevant multicellular systems allows us to dissect how signal and noise relate to functional
outcome.
We have developed biosensors and fully automated imaging platforms to simultaneously quantify multiple kinase
activities in thousands of live single cells. More recently, we have generated transgenic mouse models to monitor
signaling events in unperturbed mouse tissues and developing embryos. Using these approaches we have
uncovered spatial and temporal patterns of signaling events that filter biological noise to effect deterministic
outcomes. Our unique methodology features the high temporal resolution, sensor multiplexing capabilities, and
single cell resolution essential for studying signaling network dynamics in single cells of a multicellular system.
My research program is divided in two areas: (A) connecting single molecule behaviors to changes in cell state
and (B) connecting single cell signaling activities to collective cell behaviors. This grant cycle, we propose to
focus in four main questions: 1- What are the most upstream molecular events that engage the MAPK signaling
network? 2- How do cells monitor and adjust the biophysical properties of the cytoplasm? 3- How are the
collective properties of cytoskeleton driving cell-cell communication in tissues?, and 4- What are the mechanisms
driving the unicellular to multicellular transition in mammalian embryos? Through these fundamental questions,
our research program has expanded into several exciting new areas of modern biology including
mechanobiology, phase transitions, and the regulation of macromolecular crowding. Using genetic and
biochemical approaches coupled with powerful fluorescent biosensor and live cell imaging, we will define new
biological mechanisms that control cell biology.

Public health relevance
Project Narrative How do biological systems integrate diverse signals to produce distinct and appropriate responses? We will explore this fundamental question using genetic and biochemical approaches coupled with powerful fluorescent biosensors and live cell imaging. Understanding how biological systems make deterministic decisions based on the probabilistic nature of molecular interactions will ultimately allow better manipulation of cellular behavior in health and disease.